Discovery of phosgene and chlorine gas modes of action and therapeutic targets using chemoproteomic profiling strategies

Project Summary:
Phosgene and chlorine are two toxic gases produced on large industrial scales that pose occupational hazards
and chemical threats to the public and military. Both toxicants modify proteins in various ways and induce
oxidative stress in the lung which perturb critical functions and pathways. However, the precise nature and
sites of these modifications in the lung proteome have not been identified, and the potential chemical diversity
of these modifications poses an analytical challenge to unraveling the molecular mechanisms by which
chlorine and phosgene induce acute lung injury. This lack of biomolecular characterization of phosgene- and
chlorine-induced modification of protein targets has consequently hindered our ability to develop effective
countermeasures; there are currently no approved therapeutics for treating phosgene or chlorine gas
exposures. We propose to use chemoproteomic profiling—a subset of mass spectrometry-based proteomics
that can detect the sites and types of distinct chemical modifications to proteins—to comprehensively identify
specific proteins in the lung that have been chemically altered by phosgene and chlorine and perform pathway
analysis to identify protein candidates for future targeted countermeasure development.
The specific aims of this proposal are:
Aim 1: Dynamic redox profiling to identify the temporal protein cysteine oxidation events and global proteome
changes following gaseous toxicant exposure
Aim 2: Mapping phosgene- and chlorine-induced protein modifications in the lung using electrophilic chemical
probes
Aim 3: Data integration and network analysis to identify shared and unique molecular targets of phosgene and
chlorine for therapeutic development

Public health relevance
Project Title: Discovery of phosgene and chlorine gas modes of action and therapeutic targets using chemoproteomic profiling strategies Project Narrative: Phosgene and chlorine gas are two widely used toxic industrial gases that cause severe lung damage when inhaled. No therapeutic or antidote currently exists to treat acute phosgene or chlorine exposures. The proposed research will use chemoproteomics to uncover the molecular mechanisms of phosgene and chlorine toxicity in the lungs, which will help identify potential protein targets for future countermeasure development.